11th Latin American Society for Developmental Biology (LASDB) Conference

SUMMARY
The Congress of the Latin American Society for Developmental Biology (LASDB) is the major event in this
discipline in Latin America and has successfully been organized in different countries every two years since
2003. For pandemic reasons, LASDB meetings have not occurred since the one in Buenos Aires, Argentina in
2019. Hence, the 11th LASDB meeting, to be organized in Chile in 2024, is a very special and long-awaited
opportunity to re-connect the Latin American community by bringing together approximately 300 highly motivated
graduate students, postdocs and junior scientists from the region, as well top-notch researchers working in
different countries around the world for discussions of the recent advances in the field. This meeting will also
coincide with the inaugural meeting of the recently created Chilean Society for Developmental Biology (SBDCh)
and with the first meeting in Latin America of the Pan-American Society for Evolutionary Developmental Biology
(PASEDB) whose purpose is to integrate and help develop Evo-Devo in Latin America, a continent rich in
amazing, yet, understudied, biological diversity. The main goal of the LASDB is to promote active discussions of
the latest advances in Developmental Biology in a highly dynamic and interactive environment, favoring
synergies of ideas and networking opportunities. For preparing the list of 22 outstanding invited speakers, the
organizers of the meeting were advised by an international Scientific Committee formed by leading scientists
with previous close ties to the Latin American community, including Marianne Bronner (Caltech, USA), Roberto
Mayor UCL, London), Alfonso Martinez-Arias (UPF, Spain) and Karen Crow (UC Santa Cruz, USA). This
committee was concerned with ensuring that the list of speakers was of excellent scientific quality and had a
virtuous balance of gender, career stage, ethnicity/country of origin, topic, and model organism. Most speakers
(80%) have already confirmed their participation, 50% are women, 23% are young PIs, 27% are based in Latin
America, 32% are from the USA and 41% are from the EU/UK, and among the USA and EU/UK 25% are of Latin
American origin. A total of six scientific sessions or symposia will cover classic topics and emerging areas in the
field. Each session will have time allocated for three talks by invited speakers (30 mins each), three short talks
(15 mins each) and five flash-talks from posters (2.5 mins each) selected from submitted abstracts.

Public health relevance
NARRATIVE Funds are requested for partial support of the 2024 11th LASDB Conference to be held in the city of Valparaiso, Chile, in conjunction with the inaugural meeting of the recently created Chilean Society for Developmental Biology (SBDCh) and the first meeting in Latin America of the Pan-American Society for Evolutionary Developmental Biology (PASEDB). This Conference is intended to bring together a diverse group of scientists working on different aspects of Developmental Biology and using different experimental models and technological approaches to better understand the molecular and cellular processes controlling morphogenesis, providing a unique opportunity and format for the exchange of ideas and information and to attract/retain young postdocs and students to join this exciting research area. To provide more opportunities to early career investigators, postdocs and graduate students, we will select from the abstracts both short talks (15 mins) and flash talks (2.5 mins) to further motivate participation and interactions at the poster sessions, and will have a power hour session on career development, a meet-the-speaker session and several round tables / workshops sessions to debate topics of interests related to diversity in science, ethics, challenges of science in Latin America, developmental biology and climate change, outreach and teaching.